ADJUVANT TARGET DISCOVERY FOR VACCINES AND FOR AUTOIMMUNE AND ALLERGIC DISEASES.

Using their unique Membrane Proteome Array (MPA)technology, the contractor will screen a comprehensive library of human cell surface proteins to identify novel immunomodulatory targets that regulate dendritic cell or Toll-like receptor (TLR) activation.